Project 1: Translating Renal Xenotransplantation

ABSTRACT
Xenotransplantation using multiple gene edited (multi-GE) porcine organs is a promising approach to address
organ shortage in organ transplantation. While we have achieved long-term renal xenograft survival exceeding
one year in nonhuman primates (NHPs) using triple knockout (GalT, β4GalNT2 and CMAH KO - TKO) with seven
human transgenes, thrombotic microangiopathy (TMA) and antibody-mediated rejection (AMR) remain the
primary causes of the kidney xenograft loss. Since NHP natural antibody binding to GalT/β4GalNT KO - ‘double
knock-out’ (DKO) cells is lower than to TKO cells, and similar to human antibody binding to TKO cells, we propose
to transplant DKO kidneys with multi-GE as a more clinically relevant pretransplant model to evaluate incidence
of TMA and AMR in the context of various clinically applicable immunosuppressive (IS) regimens. In addition,
non-physiologic interactions between primate platelets and porcine von Willebrand factor (vWF), complement-
mediated injury, and ischemia-reperfusion injury (IRI) have also each been implicated in TMA incidence and
severity. Based on these considerations, we will investigate the following Aims in a well-established baboon
model. Aim 1. To establish an optimized IS regimen for kidney xenotransplantation using a pig carbohydrate
gene KO profile for NHP studies that is most relevant to predict human results; We will re-evaluate the
requirement of costimulatory blockade (CoB) in baboon recipients of TKO vs. DKO Multi-GE porcine kidneys.
Fc-modified-αCD154 mAb (TNX-1500) and non-activating αCD28 mAb (VEL-101), two clinically available
costimulatory blockade (CoB) agents, will be compared to conventional IS for their potential to reduce the
incidence of TMA/AMR. Aim 2. To evaluate humanized porcine vWF (h*pvWF) and C3- or C5-directed
complement inhibition to prevent kidney xenograft TMA; We will evaluate whether h*pvWF in Multi-GE pigs,
alone or with additional C3- or C5-directed complement inhibition, using a C3 or a C5 inhibitor, modulates TMA
following kidney xenotransplantation. Aim 3. To minimize ischemia reperfusion injury (IRI) by normothermic
machine perfusion (NMP), alone or with additional CD11b blockade. We hypothesize that minimizing IRI by
NMP and blocking CD11b, will attenuate innate immune activation and ameliorate TMA, improving kidney
xenotransplant outcomes.

Public health relevance
PROJECT NARRATIVE The proposed research studies will utilize pigs specifically designed for use in NHP preclinical models to identify an optimized immunosuppressive protocol in multi-GE pig kidney xenografts along with additional gene edits and drug treatments to prevent or reverse TMA and AMR. Results will be directly applicable to inform design of translational clinical kidney xenograft trials.